Enhancing the Interpretability and Applicability of Polygenic Scores through Multi-Omics Integration and Analysis of Family-Based Studies

Project Summary
Polygenic scores (PGS), constructed by common variants identified through large genome-wide association
studies (GWAS), are effective tools in research and clinical applications. However, the interpretation of the
functional roles of PGS—that involve hundreds to even thousands of common variants—in uncovering the
specific components of a phenotype trait or a disease outcome is challenging. This will further obscure the
interpretations of downstream analysis in identifying the causal relationships between risk factors and diseases.
The proposed project aims to address a critical need to enhance the PGS applicability in investigating disease
etiologies using cohort and family-based studies, integrating diverse sources of information including multi-omics
data and environmental exposures. In particular, the work will 1) Develop a machine learning approach and its
hypothesis testing framework to integrate trait-associated SNPs, multi-omics data, and summary-level statistics
of the trait to model the mediating mechanisms underlying genetic associations. Then construct partitioned SNP
sets or partitioned PGS (pPGS), with each partitioned component representing distinct functional regulatory
pathways linked to the GWAS trait. 2) Develop likelihood-based methods utilizing multi-trait PGS to estimate the
causal effects of multiple correlated exposures on an index disease in family-based studies, correcting for biases
from assortative mating and population stratification. 3) Identify heterogeneous causal effects of exposures using
partitioned SNP sets and pPGSxE interactions in leading causes of mortality, including cardiovascular diseases
and cancers; and identify the causal relationships of multiple maternally-mediated exposures and biomarkers on
childhood diseases, including autism spectrum disorders and orofacial clefts, through multi-ethnic case-parent
trio studies. Finally, the developed methods and results will be disseminated through user-friendly software tools
and a summary statistics database. This work will help researchers better utilize various genetic markers, rich
omics data, and environmental variables for a more comprehensive and unbiased understanding of how
molecular changes contribute to disease causalities, ultimately enhancing public health through better
interventions and treatments.
The candidate will receive training from a mentoring team of globally recognized experts in the fields of statistical
genetics, machine learning, genomics, epidemiology, and subject-matter expertise in cardiovascular diseases,
cancer, and mental health; supported by a vibrant intellectual environment at Johns Hopkins University with
seminars, collaborations, career development resources, and advanced coursework. This award will allow the
candidate to gain critical skills in research, mentoring, communication, and leadership that will ensure success
in her long-term goal of establishing an independent research program, focused on pioneering the development
of innovative computational methods to advance human health through large-scale dataset integration.

Public health relevance
Project Narrative This proposal aims to create a series of new statistical methods to help us better utilize genetic scores in the study of the causes behind intricate human diseases. It will incorporate multi-omics data to facilitate molecularly- informed disease pathways and assess the impact of each pathway on the disease, and also use family-based studies to provide unbiased investigations of how multiple correlated environmental factors or biomarkers influence diseases. It will further provide easy-to-use software tools and a summary statistics database for researchers to analyze large-scale multi-modal data to accelerate future research, enabling a more comprehensive and unbiased understanding of how molecular changes contribute to human diseases.